A multimodal approach for immunotherapy of Staphylococcus aureus bacteremia

Staphylococcus aureus (S. aureus; SA) colonizes >50% of people and causes a wide range of diseases
including bacteremia, pneumonia, and surgical site infections. No SA vaccines or immunotherapeutics are
approved or in late-stage clinical development. Recent findings revealing the detrimental impact of prior
exposure to SA on shaping the immune response to SA vaccine candidates highlight the importance of not only
targeting bacterial growth, but also the immune evasion mechanisms of SA as treatment options. This proposed
project seeks to develop an immunotherapeutic antibody cocktail for treatment of SA bacteremia (SAB) that
targets multiple mechanisms of growth and immune evasion by SA through targeting three key factors. SA
pore-forming toxins (PFTs) including leukocidins and hemolysins target the innate immune cells, as well as T
cells that are required for protection against SA, and cells with barrier function required for containment of
infection. These toxins also kill erythrocytes to extract iron for bacterial growth. SA protein A (SpA) binds to
Fc and interferes with the complement mediated effector functions. SpA, through binding to VH3 Fabs, also
acts as a B cell superantigen triggering polyclonal expansion followed by deletion of B cells bearing VH3 B cell
receptors. SpA blunts the humoral responses to other SA antigens. SA autolysin (Atl) is a peptidoglycan-
cleaving enzyme essential for productive division of SA cells. Clinical outcome in patients undergoing surgery
after SA prosthetic joint infection correlates with antibodies to glucosaminidase (Gmd) domain of Atl. While
humans have anti-Gmd IgG from SA infections and/or colonization, eliciting neutralizing antibodies is extremely
rare. But in non-human primates (NHPs) we were able to induce high neutralizing titers upon vaccination with
recombinant Gmd. We hypothesize that combined neutralization of PFTs, SpA, and Gmd during SAB and other
invasive SA infections protects against SA invasive disease by antibacterial activity (anti-Gmd), protecting the
immune cells (anti-PFT), helping with complement and macrophage mediated clearance of bacteria (anti-SpA
and anti-Gmd), and by expanding immune responses to other SA antigens (anti-SpA). Using our mAb discovery
platform we have already identified highly potent mAbs from macaques and humans against a wide range of
SA toxins including a fully human mAb that cross-neutralizes five PFTs. This antibody combined with an anti-
Gmd mAb protects in murine models of SAB and pneumonia. Furthermore, for the first time we have developed
a novel nonhuman primate (NHP) model of SAB, that will be used in this project. In this project we will identify
additional mAbs against these targets (Aim 1), determine the epitopes and crystal structures of at least one
antigen-mAb complex in each group (Aim 2), evaluate the impact of neutralization of SpA on the outcome of
immune response to SA infection in NHPs and evaluate the efficacy of a cocktail of three mAbs in guinea pig
model of SAB (Aim 3). With this study, we expect to build the foundation for the development of an effective
immunotherapy of SA invasive diseases.

Public health relevance
Staphylococcus aureus (SA), in particular methicillin-resistant SA (MRSA) is a major human pathogen causing significant mortality and morbidity in the US and around the world. There is no vaccine available for this pathogen. In this project we intend to develop a novel immunotherapeutic antibody cocktail for treatment of S. aureus bacteremia, one of the most consequential diseases caused by MRSA.